Gene expression in the human brain

We have focused on developing datasets for gene expression to study the effects of mutations in the genes associated with neurodegeneration including Alzheimers disease. Using RNA-Seq allows us to apply a standard set of methods to a variety of model systems. Using this approach we have contributed to a number of different studies. One of the most interesting areas is in the application to the human brain, where we have a large series of brains with information on both genetic variability and gene expression. Our data has been used in many studies to determine whether a nominated genetic variant associated with a given disease (such as Alzheimers) or other phenotype, has a proximal biological effect on gene expression. We have used our datasets to recently study variation around the SNCA gene, which encodes for the protein a-synuclein. GWAS nominated risk variants were associated with higher levels of specific mRNA transcripts arising from this gene. We are currently extending these efforts to include single cell level analyses.